Emory/Georgia TB Research Advancement Center (TRAC)

The Administrative Core is the central coordinating body of the Emory/Georgia Tuberculosis Research
Advancement Center (TRAC) with responsibility for providing leadership, influencing TB research priorities,
allocating resources, and advancing the growth of new TB research at Emory University and partners at:
University of Georgia, Georgia Institute of Technology, Georgia State University and Morehouse School of
Medicine. The Administrative Core will be Co-Directed by Drs. Neel Gandhi and Jyothi Rengarajan who will
provide overall direction and management for the TRAC. Dr. Kenneth Castro will serve as Associate Director
and coordinate TRAC strategic planning, evaluation, and community engagement activities. These three
distinguished TB researchers recently co-founded the Emory Tuberculosis Center, and bring complementary
expertise spanning the spectrum of TB research: clinical & epidemiologic research (Gandhi), basic &
translational research (Rengarajan) and public health & policy implementation (Castro).
The main objectives of the Administrative Core are: Aim 1: to provide strategic vision for the
Emory/Georgia TRAC via effective and dynamic leadership; Aim 2: to effectively manage center resources and
evaluate outcomes; Aim 3: to promote growth in TB research through recruitment of key scientific faculty,
multidisciplinary collaborations, and the mentorship and development of early-stage investigators; and Aim 4:
to facilitate communication and dissemination of Emory/Georgia TRAC activities across Emory, our partner
institutions, and the broader scientific community.
The Administrative Core will oversee and facilitate the activities of the Developmental Core and the three
Scientific Cores: Clinical & Population Science Core, Basic & Translational Science Core and the
Bioinformatics & Integrated Systems Biology Core, to achieve the overall goals of expanding
multidisciplinary TB research and developing the next generation of TB researchers. The Administrative Core
will be assisted by the Executive Council to create the TRAC Strategic Plan, with advice and guidance from the
Internal Advisory Board, External Advisory Boards and the Community and Public Health Advisory Council.
The Administrative Core will ensure that the TRAC’s strategic goals are met through efficient day-to-day
operations, grant management, and compliance with NIH and federal policies. Finally, communication and
dissemination of the activities, opportunities, and accomplishments of our TRAC are critical to our success and
are essential for the growth and development of researchers, improving rigor and impact, catalyzing new
collaborations, and building community; thus, coordination of the TRAC Communications Plan and
Dissemination Program will be an important responsibility of the Administrative Core.